Omega-3 PUFA suppress adipochemokines in human obesity

DESCRIPTION (provided by applicant): Obesity and its resultant complications represent a major public health; further understanding of the underlying pathophysiology will aid the development of preventive and therapeutic modalities. As a pediatric endocrinologist, the P.I. Dr Shah has a committed interest in studying the early mechanistic processes involved in obesity-related metabolic dysregulation, with the hope of exploring novel preventive and treatment options. Her ultimate career goal is to become an independent translational researcher in the field of endocrinology, with a focus in obesity and adipose tissue biology across the pediatric and adult age spectrum. Through her current work with her mentor and training in the Masters in Translational Research program, she has developed essential skills and experience in clinical and translational research. This will allow her to perform the work proposed in this application, which integrates a human clinical trial with studies in human tissues and cells to explore novel pathways in obesity-related adipose inflammation. To acquire further expertise and knowledge as she transitions to independence, Dr Shah has devised a comprehensive career development plan that takes full advantage of the rich research, educational, and collaborative environment at the Children's Hospital of Philadelphia and the University of Pennsylvania. Dr Shah's career plan includes strong mentorship in translational research, didactic coursework in genetics, immunology, and bioinformatics, focused training in necessary laboratory skills and aspects of clinical research, scientific enrichment and professional development through attendance of intra- and extra-mural, seminars and conferences, and clearly delineated steps to independence. She has the full support of the Department of Pediatrics and Division of Endocrinology to ensure adequate time and resources for this training. Additionally, she will receive guidance through her mentors, Dr Muredach Reilly and Dr Karen Teff, and a carefully selected advisory committee of experts in critical areas of her proposed research. In order to complete her proposed studies, Dr Shah will have access to resources in the Penn/CHOP CTSA-sponsored Clinical and Translational Research Center (CTRC), Dr Reilly's laboratory, core facilities, and statistical expertise. Through the completion of the research and educational plans outlined in this application, Dr Shah will gain the experience necessary to establish an independent translational research program exploring mechanisms in obesity across the adult-pediatric spectrum. Murine long-chain omega-3 polyunsaturated fatty acids (LC n-3 PUFA) are used clinically to treat dyslipidemia and are demonstrated in pre-clinical cell and rodent models to decrease adipocyte and monocyte inflammation and prevent adipose leukocyte infiltration during high-fat feeding; in vivo human data, however, is lacking. A key driver of adipose inflammation and macrophage infiltration is adipochemokine signaling, including the CCL2-CCR2 and CX3CL1-CX3CR1 pathways. Whether LC n-3 PUFA anti-inflammatory actions in adipose are mediated via these chemokine systems is suggested by decreased CCL2 levels in mice fed n-3 PUFA but has not specifically been explored, The mechanisms by which LC n-3 PUFA exerts anti-inflammatory effects in adipose are also not clearly defined. Recently a LC n-3 PUFA receptor, GPR120, has been identified that in mouse and cell models appears to modulate n-3 PUFA inhibition of nuclear factor kappa beta (NF signaling to decrease inflammation in cells and adipose tissue. In humans, loss of function of GPR120 confers increased risk of obesity. Together these findings suggest a potential mechanism by which LC n-3 PUFA attenuates obesity- related adipose inflammation. We hypothesize that LC n-3 PUFA modulate adipocyte-macrophage chemokine signaling (CCL2-CCR2 and CX3CL1-CX3CR1) to decrease systemic and adipose inflammation via GPR120 inhibition of NF- B signaling. This application addresses the following hypotheses: 1) LC n-3 PUFA treatment of primary human adipocytes in vitro suppresses chemokine-induced adipocyte inflammation and adipocyte-monocyte interactions via GPR120 2) LC n-3 PUFA treatment of human monocytes and macrophages in vitro modifies CX3CL1-CX3CR1 and CCL2-CCR2 to reduce the inflammatory state of these leukocytes and resultant interactions with adipocytes in a GPR120-dependent manner and 3) treatment of obese human subjects with the n-3 PUFA supplement Lovaza, compared to placebo, regulates the CX3CL1-CX3CR1 and CCL2-CCR2 chemokine systems to reduce inflammatory leukocyte recruitment into human adipose. In vitro studies in primary human cells will assess effects of individual n-3 PUFAs and GPR120 agonists on baseline and inflammatory stimulated chemokine signaling, CX3CL1-CX3CR1 and CCL2-CCR2 induced monocyte-adipocyte adhesion and migration, and.NF activation. Knockdown of GPR120 and NFkB will be used to determine whether anti- inflammatory effects are modulated by these pathways. For the clinical trial, obese, non-diabetic subjects will be treated for 8 weeks with Lovaza or placebo; visits are planned at baseline and 8 weeks for assessment of insulin sensitivity, adipose and blood chemokine levels, NF signaling factors, and adipose and circulating CX3CR1- and CCR2-expressing macrophage and monocyte quantification via flow cytometry.

Public health relevance
PUBLIC HEALTH RELEVANCE: The epidemic problems of obesity and related type 2 diabetes have a huge global impact, but the mechanisms by which excess weight cause diabetes are not fully understood, and there are limited treatments to prevent this process. This research will lead to greater understanding of how inflammation of fat tissue leads to metabolic disruptions in obesity, and whether fish oil supplements can help reverse these changes. The findings may uncover another beneficial effect of a common dietary supplement, leading to better preventive and treatment strategies __SpecificAimsTextDelimiter__ Specific Aims Murine long-chain omega 3 polyunsaturated fatty acids (LC n-3 PUFA) include DHA (docosahexaenoic acid) and EPA (eicosapentaenoic acid) and are widely used for the treatment of dyslipidemia. Beyond lipid effects, LC n-3 PUFA are suggested in vitro and in vivo animal models to reduce obesity-related systemic and adipose inflammation, including adipose chemokines integral to adipose inflammation and inflammatory macrophage infiltration. [Recently a LC n-3 PUFA receptor, GPR120, was demonstrated to modulate anti-inflammatory effects in rodents via inhibition of nuclear factor kappa beta (NF signaling, suggesting a potential mechanism for LC n-3 PUFA anti-inflammatory effects in human.] Adipose inflammation, induced by inflammatory leukocyte infiltration, is a crucial link between obesity and its metabolic complications. Chemokine pathways including monocyte chemotactic protein (CCL2) and fractalkine (CX3CL1) and their receptors CCR2 and CX3CR1 have been documented in animal and human models to modulate insulin resistance and type 2 diabetes by regulating adipose macrophage recruitment and activation. Variable expression of CCR2 and CX3CR1 is a critical determinant of monocyte survival and inflammatory state and delineates two distinct populations: pro-inflammatory CX3CR1loCCR2+ monocytes associated with classically-activated, inflammatory (M1) adipose macrophages vs. less inflammatory CX3CR1hiCCR2- thought to give rise to alternatively-activated (M2) adipose macrophages. Metabolic and inflammatory stimuli associated with obesity induce release of chemokines that promote disproportionate migration and adhesion of pro-inflammatory CX3CR1loCCR2+ monocytes and/or shift of M2 to M1 macrophages. Currently, the effects of LC n-3 PUFA on human adipose chemokine pathways has not been explored, nor has the mechanism of n-3 PUFA anti-inflammatory effects on chemokine-induced adipose inflammation. In preliminary studies, we show that LC n-3 PUFAs ameliorate inflammatory chemokine production in adipocytes and ex vivo in obese human adipose tissue. Additional we demonstrate in vivo that inflammatory induction of cytokines and chemokines in human plasma are blunted by LC n-3 PUFA supplementation. The goal of this proposal is to reveal, through human translation, whether LC n-3 PUFA modulates adipocyte-macrophage CCL2-CCR2 and CX3CL1-CX3CR1 signaling to decrease systemic and adipose inflammation via modulation of GPR120 and NF . [Aim 1: Determine effects and mechanism of LC n-3 PUFA treatment on human adipocyte inflammation and chemokine signaling. Utilizing in vitro studies of baseline and inflamed human adipocytes, we will test the hypothesis that pre-treatment of human adipocytes with exogenous LC n-3 PUFA (DHA and/or EPA) and/or a GPR120 agonist (GW9508) will reduce baseline and inflammatory stimulated (a) CCL2 and CX3CL1 expression and secretion, (b) CX3CL1- and/or CCL2-dependent monocyte adhesion and migration to adipocytes, and that (c) NF- activation. Mechanistic studies in adipocytes with shRNA knockdown of GPR120 and NF and in human adipocytes with and without functional polymorphism in GPR120 will further delineate the role of this pathway on LC n-3 PUFA effects on inflammation and chemokine signaling.] [Aim 2: Establish effects and mechanism of LC n-3 PUFA on human monocyte and macrophage inflammation and chemokine signaling. In vitro studies of human monocytes and differentiated macrophages will be used to assess the effect of LC n-3 PUFA (DHA and/or EPA) to test the hypothesis that LC n-3 PUFA supplementation (a) will exert anti-inflammatory effects on human monocytes and macrophages during basal and evoked inflammatory conditions, including switching of surface chemokine receptors, (b) will decrease chemokine-dependent monocyte adhesion and migration to adipocytes, and (c) shRNA knockdown of GPR120 and NF will block LC n-3 PUFA anti-inflammatory effects.] Aim 3: Determine whether LC n-3 PUFA decrease human adipose tissue inflammation, and inflammatory monocyte and macrophage infiltration through CCL2-CCR2 and CX3CL1-CX3CR1. In a placebo-controlled trial of obese non-diabetic subjects, we will study the effect of 8 weeks of treatment with LC n-3 PUFAs (Lovaza 4 grams/day; 1.86 grams EPA and 1.5 grams (DHA). We hypothesize that Lovaza will decrease (a) adipose and circulating CCL2 and CX3CL1 mRNA and protein and NF signaling factors (b) circulating ratio of pro-inflammatory (CX3CR1loCCR2+): less inflammatory (CX3CR1hiCCR2-) monocytes, and (c) M1:M2 adipose tissue macrophages relative to placebo and that (d) these changes correlate with improvements in insulin sensitivity and other metabolic parameters. In summary, we propose that adipochemokine pathways implicated in obesity-related inflammation are -3 PUFA in adipocytes, monocytes and adipose macrophages to reverse adipose inflammation and inflammatory monocyte infiltration, and [that these responses are mediated by GPR120 inhibition of NF signaling]. Characterization of these effects will provide important mechanistic insights and a human context for novel therapeutic applications in the prevention and treatment of obesity-related disease.